Patient-Oriented Research in Arginine Deficiency Syndromes

This K24 renewal application entitled “Patient-Oriented Research (POR) in Arginine (ARG) Deficiency Syndromes” seeks 5 years of additional support for protected time to maintain the principal investigator’s (PI) mentoring activities, promote her career development & provide ongoing momentum to advance the applicant’s research evaluating ARG therapy in sickle cell disease (SCD) and beyond. ARG is a nutritional supplement & obligate substrate for production of nitric oxide, a potent vasodilator that depletes during SCD-related pain episodes. The PI & her mentees have completed several randomized, double-blinded, placebo-controlled trials (RCT) of ARG therapy in children with SCD & pain requiring hospitalization in both the US & Nigeria. These studies combined found that ARG replacement therapy (ART) has opioid-sparing effects, improved pain scores & cardiopulmonary function, decreased pain medication use & time-to-crisis-resolution and was associated with a shorter hospital stay compared to placebo. The PI and colleagues also observed a dose-dependent impact of ART that improved mitochondrial function & decreased oxidative stress in children with SCD-pain. With recent NHLBI funding for a multicenter Phase 3 RCT utilizing the Pediatric Emergency Care Applied Research Network (PECARN), the PI plans to perform the definitive study - Sickle Cell Disease Treatment with Arginine Therapy (STArT) to determine the efficacy & safety of ART. Pain in SCD is the leading cause of emergency room (ED) visits & hospitalizations, associated with an increased mortality rate. There are no current therapies to treat the underlying mechanisms of acute pain, with interventions limited to hydration & analgesia. The PI hypothesizes that ARG is a safe & inexpensive nutritional supplement with opioid-sparing effects in children with SCD & pain. The STArT trial will provide essential data for product development & will ultimately help gain FDA product approval for SCD if benefits of ART are confirmed. The results of this proposal may ultimately lead to a change in clinical practice for patients with SCD and targets an NCCIH strategic priority of non-pharmacologic management of pain. The PI is highly committed to performing POR focused on nutrition science and in growing her mentorship reach to include undergraduates, graduate & medical students, post-doctoral fellows & junior faculty in clinical nutrition research. The environment at Emory University is ideal to foster these goals, through partnership with the Georgia Clinical & Translational Science Alliance (CTSA). The CTSA provides additional institutional infrastructure & enriches access to mentees for the K24 applicant, who is one of 140 participating CTSA faculty.

Public health relevance
This research addresses a critical public health need by developing effective treatments for sickle cell disease (SCD), which can significantly reduce pain and improve quality of life for affected individuals. Additionally, it aims to train the next generation of clinical scientists in integrative medicine, ensuring continued advancements in patient care and public health.